In vivo analysis of endodermal and dorsal forerunner cell migration

PROJECT SUMMARY
In the developing embryos, the formation of organs and tissues arises from the collective actions of many
individual cells which may change their shape, size, adhesion, and motility. Our long-term goal is to understand
how these cellular behaviors are regulated in both space and time to correctly build each tissue and organ. In
this project, we will leverage two closely related yet phenotypically distinct cell types, the endodermal and dorsal
forerunner cells in zebrafish embryos, to better understand the regulation between migratory mesenchymal
states and coherent epithelia. During early gastrulation, endodermal cells exhibit mesenchymal characteristics;
they are highly migratory, spatially dispersed, and avoid contact with each other. In contrast the dorsal forerunner
cells are tightly associated with each other and display epithelial characteristics, even as they migrate
collectively. Remarkably, both cell types are specified by the same developmental signals and express many of
the same marker genes, despite their divergent migration behaviors. In Aim 1 of this project, we will use single-
cell RNA sequencing and bioinformatic analysis to compare the transcriptional profiles of endodermal and dorsal
forerunner cells and identify differentially expressed candidate genes likely involved in the regulation of cell
migration modes. In Aim 2, we will generate split fluorescent protein knock-in zebrafish lines to characterize the
expression and localization of key endodermal and dorsal forerunner genes. This approach is based on
technology developed in the parent grant to this diversity supplement application. If successful, this study will
identify key genes responsible for different modes of migration in two closely related, yet distinct cell types. Our
findings will shed light on the broader question of how small differences in transcriptional states translate into
major differences in cellular behavior.

Public health relevance
PROJECT NARRATIVE The ability of a developing embryo to form organs and tissues relies on careful regulation of cellular behaviors, which includes regulating where, when, and how cells migrate and interact with each other. Failure to do so can result in birth defects or leave the individual susceptible to developing disease later in life. In this project, we are studying two different cell types called endodermal cells and dorsal forerunner cells that migrate in very different ways in order to find key genes responsible for regulating cell migration.